Astrocyte-specific in vivo molecular signatures of APOE genetic risk in Alzheimer's disease

PROJECT ABSTRACT
Alzheimer’s disease (AD) is a common and burdensome neurodegenerative disease. Apolipoprotein E
(APOE) is the most prevalent risk factor for developing AD. APOE genotype may contribute to disease
pathogenesis and risk by impacting astrocyte molecular profiles and subsequent biological functions. Data from
my lab in human post-mortem AD and control brain proteomes identified a module of co-expressed astrocytic
and microglial proteins in APOE ε4 individuals that were involved in sugar metabolism and inflammation and
strongly correlated with the MAPK/ERK pathway. Because astrocytes are abundant throughout the brain,
produce high levels of apoE protein, and play a critical role in brain homeostasis, they are more likely to contribute
to disease vulnerability and pathogenesis of AD in the context of APOE risk. To address how APOE genotype
impacts astrocyte function, my laboratory recently developed cell type-specific in vivo biotinylation of proteins
(CIBOP) as a novel approach to quantify the total and phospho-proteomes of astrocytes in their native state
without the need for cell isolation. In this approach, the biotin ligase, TurboID, is selectively expressed in the cell
type of interest using a conditional Cre/lox genetic strategy. Using astrocyte-CIBOP in our preliminary studies,
we have successfully obtained native-state proteomes of astrocytes from mouse brain, and quantified astrocyte-
derived cytokines and MAPK/ERK signaling phospho-proteins. Leveraging this highly innovative methodology,
my goal in the current study is to for the first time define the astrocyte-like immune response to APOE ε4 genotype
and determine if the MAPK/ERK pathway is a mechanism of this response. My central hypothesis is that APOE
ε4 genotype augments pro-inflammatory profiles of astrocytes via increased cytokine and complement
production in an ERK signaling-dependent manner. I will use the astrocyte-CIBOP mice derived on homozygous
human APOE 4/4 and APOE 3/3 knock-in genetic backgrounds to determine the differential impacts of APOE
genetic risk on molecular signatures of astrocytes in vivo. In Aim 1, I will test the hypothesis that APOE 4/4
astrocytes, compared to APOE 3/3, will exhibit elevated levels of pro-inflammatory cytokines, increased
complement protein production, amplified MAPK/ERK signaling, and aberrant changes in lipid metabolism. In
Aim 2, I will test the hypothesis that the exaggerated pro-inflammatory response of APOE4 astrocytes, initiated
by systemic inflammatory challenge (LPS), is mediated via ERK signaling. Using bioinformatic approaches on
proteomic and transcriptomic data and validation IHC approaches in mouse and human brain tissues, I will
identify molecular changes in reactivity states of APOE 4/4 and 3/3 astrocytes in vivo and identify ERK-
dependent and ERK-independent mechanisms of APOE. My work will lay the foundation to further investigate
astrocyte-mediated mechanisms of AD pathogenesis to employ CIBOP in future studies to explore cell type-
specific mechanisms of neurodegeneration, beyond AD and astrocytes.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a prevalent and burdensome neurodegenerative disease with no highly effective therapeutic to slow the progression of the disease. Since the molecular mechanisms that mediate the effects of APOE risk factors for AD progression remain unclear, there is a critical need for preclinical research to identify novel ways to diagnose and treat AD in humans. Therefore, this proposal will test the hypothesis that APOE genotype risk factors for AD impact the molecular profiles of astrocytes and change their inflammatory and metabolic phenotypes and contribute to AD pathogenesis.